Shared Resource Management

Shared Resource Management: Summary/Abstract
The HDFCCC supports shared resources to ensure HDFCCC members have access to the technologies and
expertise necessary for their research. This is accomplished by providing centralized management and
oversight of shared resource operations; monitoring service quality and user feedback; and providing
mechanisms for members to easily access any service within the HDFCCC shared resources or elsewhere on
campus. The ability of HDFCCC shared resources to provide access to specialized technologies, services, and
expertise that enhance scientific interaction and productivity is evident in the high number of users of shared
resources across all seven CCSG programs.